MRI and X-ray catheter design and prototyping

We have invented several first-in-class interventional devices for novel therapeutic non-surgical procedures. These include devices for trans-atrial catheter-based tricuspid valve repair, transcaval access to the aorta to enable transcatheter aortic valve replacement in patients with no good options, extra-anatomic bypass for congenital heart disease without surgery, devices to slice mitral and aortic valve leaflets that otherwise would cause life-threatening obstruction of heart chambers or arteries, devices to squeeze the heart muscle to treat heart failure, devices to slice the heart muscle to treat different kinds of heart failure, and devices to destroy sources of dangerous heart rhythms. Many of these include inventions and patent applications for novel medical devices, such as purpose-built closure devices for transcaval access to the aorta, novel intramural implants to treat cardiomyopathy, and novel catheter tools for structural heart interventions.

We also work with industry to translate our laboratory inventions into the private sector for patient care. We have entered into collaborative research and development agreements with a large catheter company, research agreements with small catheter company to co-develop some devices.